ChimeraX -- Next Generation Visualization and Analysis Software for Multiscale Modeling

PROJECT? ?SUMMARY/ABSTRACT The? ?goal? ?of? ?this? ?project? ?is? ?to? ?enable? ?scientific? ?discovery? ?and? ?advances? ?in? ?biomedical? ?research? ?through the? ?development? ?of? ?cutting-edge? ?software? ?tools? ?that? ?provide? ?integrated? ?visualizations? ?and? ?analyses? ?of molecular? ?structures? ?and? ?related? ?biological? ?information.? ?? ?Our? ?tools? ?can? ?be? ?applied? ?to? ?diverse? ?types? ?of biomolecular? ?data,? ?including? ?atomic-resolution? ?coordinates,? ?3D? ?cryo-EM? ?density? ?maps,? ?and? ?protein and? ?nucleic? ?acid? ?sequences,? ?annotations,? ?and? ?networks.? ?We? ?focus? ?on? ?unmet? ?software? ?needs? ?for? ?basic and? ?applied? ?biomedical? ?research? ?using? ?highly? ?trained? ?and? ?talented? ?staff,? ?with? ?excellent? ?interdisciplinary knowledge? ?and? ?specialized,? ?state-of-the-art? ?expertise? ?in? ?software? ?engineering,? ?computer? ?graphics visualization,? ?and? ?data? ?analysis.? ?? ?Our? ?primary? ?efforts? ?are? ?in? ?the? ?interactive? ?visualization? ?and? ?analysis? ?of structures? ?of? ?molecules,? ?molecular? ?assemblies,? ?and? ?protein? ?sequence-structure? ?relationships.? ?? ?These areas? ?are? ?critical? ?for? ?addressing? ?important? ?and? ?highly? ?relevant? ?biomedical? ?problems? ?such? ?as identifying? ?the? ?molecular? ?bases? ?of? ?disease,? ?identifying? ?targets? ?for? ?drug? ?development,? ?designing? ?drugs, and? ?engineering? ?proteins? ?with? ?new? ?functions.? ?? ?Our? ?software? ?tools? ?enable? ?scientists? ?to? ?understand, analyze,? ?and? ?illustrate? ?to? ?others? ?the? ?important? ?principles? ?of? ?molecular? ?structure,? ?function,? ?and interactions.? ?These? ?tools? ?are? ?widely? ?recognized? ?as? ?works? ?of? ?the? ?highest? ?quality,? ?and? ?are? ?available? ?for free? ?on? ?our? ?website? ?in? ?binary? ?and? ?source-code? ?form.? ?? ?We? ?support? ?and? ?maintain? ?these? ?tools,? ?and provide? ?detailed? ?documentation? ?and? ?tutorials.? ?Our? ?technological? ?developments? ?are? ?disseminated widely? ?via? ?scientific? ?publications,? ?lectures,? ?software? ?distribution,? ?and? ?video? ?animations.

Public health relevance
PROJECT NARRATIVE The interactive scientific visualization software tools we develop directly address many of the critical challenges researchers face as they discover, analyze, and chronicle the major biological processes inherent in life and human disease. Our software enables spatially complex experimental data that often varies over time to be visualized and analyzed and, thus, directly leads to the intellectual understanding of important principles in biomedicine. We strive to promote the application of interactive 3D visualization and analysis techniques to critically important cutting-edge problems in structural and computational biology, and to provide insight into molecular and cellular function that can be directly applied to problems relevant to both translational biomedical research and precision medicine.